DP21-001 COMPONENT A - MISSOURI PREGNANCY RISK ASSESSMENT MONITORING SYSTEM

PROJECT ABSTRACT – COMPONENT A (CORE SURVEILLANCE)
The Pregnancy Risk Assessment and Monitoring System (PRAMS) was initiated in 1987 as
part of the Centers for Disease Control and Prevention (CDC) initiative to reduce infant
mortality and low birth weight. In recent years, the program has been expanded in support
of CDC’s Safe Motherhood Initiative to promote healthy pregnancies and the delivery of
healthy infants. PRAMS is an ongoing, population-based surveillance system designed to
identify and monitor selected maternal experiences and behaviors that occur before and
during pregnancy and during the child’s early infancy among a stratified sample of women
delivering a live birth.
Missouri PRAMS has been collecting data since 2007 about the health and well-being of
women before, during and shortly after pregnancy and during the child’s early infancy.
These data are not routinely available from other sources and can be used to identify groups
of women and infants at high risk for health problems and adverse pregnancy / birth
outcomes. Missouri PRAMS data is also extremely helpful in monitoring changes in health
status of women and children in the state, identification of emerging health issues and
measuring progress towards goals in improving the health of mothers and infants in
Missouri.
Missouri PRAMS uses a standardized data collection methodology developed in accordance
with the CDC PRAMS Model Surveillance protocol required for all PRAMS grantees. This
standardized approach allows for comparisons among states and for optimal use of the data
for single-state or multistate analysis. Each month, a stratified random sample of women
delivering a recent live birth is drawn from the state’s birth certificate file and data is
collected from this sample of women through mail and telephone modes. The data is
weighted so that findings can be applied to the state’s entire population of women with a
recent delivery.
Missouri PRAMS continues to be a key resource for program planning, improvement,
evaluation and policy development. During this project cycle, Missouri PRAMS will
continue to collect high quality data and will further enhance its efforts towards data
analysis, linkages, dissemination and translation with a life-course perspective approach.

Public health relevance
PROJECT NARRATIVE The Pregnancy Risk Assessment Monitoring System (PRAMS) is a survey sent to a sample of Missouri women with a recent live birth, asking for information about their experiences, behaviors and attitudes before, during and shortly after their most recent pregnancy. Missouri PRAMS data helps identify groups of women and infants at high risk for health problems and adverse pregnancy/birth outcomes. The goal of the Missouri PRAMS project is to improve the health of mothers and infants by reducing adverse pregnancy outcomes.